The role of supporting cell de-differentiation in cochlear hair cell regeneration

PROJECT SUMMARY
Cochlear Hair Cell (HC) loss is a leading cause of noise-induced and age-related hearing loss
worldwide. Regeneration of HCs in response to damage has been observed in nonmammalian species, such
as birds and fish, but is not observed in the mature mammalian cochlea. Although Supporting Cells (SCs), a
diverse population of cells offering metabolic and structural support to hair cells, show the capacity to produce
hair cells in neonatal mice, this plasticity is lost by postnatal day 5. Previous work from our lab has identified
the de-differentiation of SCs into a more progenitor-like state as a key component of the HC regenerative
process, as hair cells and supporting cells arise from a common progenitor pool during cochlear development.
Supporting cell de-differentiation, the downregulation in expression of supporting cell-specific genes and
upregulation in expression of, allows the progenitor-like cells to respond to HC fate-inducing cues.
Preliminary studies have identified members of the NFI and ZBTB families of transcription factors as
potential regulators of SC identity, maintaining SCs in a terminally differentiated state and preventing
endogenous reprogramming. The NFI factors have previously been studies in the context of retinal
regeneration, where they have been shown to regulate retinal Müller glial cell differentiation. Additionally,
disruption of NFI factor function has been shown to promote conversion of Müller glia into retinal neurons.
Zbtb20 has been implicated in astrocytogenesis, and has been linked to Primrose syndrome, a rare
developmental disorder which is known to cause hearing loss.
The overarching hypothesis of this grant proposal is that Nfia/b/c/x and Zbtb20 are crucial in
maintaining SC identity, and that loss of one or more of these factors will enable SC reprogramming
and HC regeneration in stage P5 mouse tissue. This hypothesis will be tested using in vitro cochlear
organoid culture derived from stage P2 and P5 murine cochlear sensory epithelia. Additionally, the function of
Zbtb20 will be studied in vivo and in a HC damage model. I will use RT-qPCR, fluorescence imaging of a HC
reporter line, immunolabeling, EdU pulse experiments, and scRNA-sequencing in Aim 1 to determine if gain of
function of NFIA/B/C/X or ZBTB20 inhibits cochlear SC reprogramming and SC-based HC formation at stage
P2 in vitro and in Aim 2 to determine if loss of function of NFIA/B/C/X or ZBTB20 enhances cochlear SC
plasticity and SC-based HC formation at stage P5 in vitro. In Aim 3, I will use immunolabeling, RT-qPCR, EdU
pulse experiments, and a HC damage model to define the role of Zbtb20 in maintaining SCs in a terminally
differentiated state. These studies will expand our knowledge of SC identity maintenance and the HC
regenerative process and will aid future translational research using regenerative therapies to treat hearing
loss in humans.

Public health relevance
PROJECT NARRATIVE Cochlear hair cell loss is a leading cause of noise-induced and age-related hearing loss worldwide. Although surrounding supporting cells show the capacity to produce hair cells in neonatal mice, this plasticity is lost by postnatal day 5. This grant proposes to examine transcription factors hypothesized to be important in maintaining supporting cell fate, with the goal of establishing a gene therapy strategy to regenerate hair cells in vitro.